Developing a clinical and research framework for evaluating inflammation pathway dysregulation in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD) is the most common cause of dementia worldwide. In the US, it is the fifth leading
cause of death in people over 65 years of age. Delineating factors that predict rate of future cognitive decline
and dementia are important but are yet to be thoroughly understood. Knowledge of disease progression related
biological factors will be critical in designing novel therapeutic strategies to mitigate their deleterious effects and
thereby prevent the associated cognitive and behavioral decline.
The research at the foundation of this R03 is a clinical translational study that uses bioinformatics and large data
analysis techniques to characterize the transcriptional and clinical context of dysregulated inflammatory pathway
changes in the brain and periphery that impact longitudinal cognitive decline in different stage of AD. This
information will be integrated with prior data on known biomarkers of AD to develop a clinically useful model to
focus better targeted patient care. Our earlier work among clinical AD patients at the Mild cognitive impairment
stage the disease studies suggest that a clinically meaningful degree of rapid cognitive decline was best
predicted by baseline levels of an inflammatory marker, CCL2. In this work we hope to extend this initial insight
by characterizing in depth the genetic drivers behind the inflammatory deregulation in clinical AD in the periphery
and the central nervous system. We will confirm and validate these changes with genome wide (RNA-seq)
expression changes and against data from other large national data (Alzheimer's Disease Neuroimaging
Initiative, Accelerating Medicines Partnership-AD and Harvard Brain Tissue Resource Center). These results will
be integrated with our knowledge of temporal changes in established AD biomarkers in different clinical stages,
to develop a clinically useful framework. The scientific insights and clinical models from this research will help
target novel inflammation based therapeutic targets in the most effective stage of AD among clinical patients
after taking into account individual variability for deleterious inflammatory responses. This is a much needed
step for future precision medicine interventions against neuroinflammation in AD to prevent disease progression.

Public health relevance
PROJECT NARRATIVE The current project addresses a major gap in our knowledge of inflammation related changes that impact rate progression in Alzheimer's disease (AD). Our early work suggests that a clinically meaningful degree of rapid cognitive decline in the mild cognitive impairment stage of AD was best predicted by cerebrospinal fluid CCL2 levels. This project will establish the temporal changes of key driver genes related to inflammatory changes of CCL2 over distinct clinical stages of AD and develop a clinical and research framework. This project is highly relevant to Public Health given that the findings will provide fundamental knowledge that can be used to develop treatments to stage and mitigate cognitive decline in AD and improve clinical care.